Dissect Mechanism of Iron(II)/2-Oxoglutarate Dependent Enzymes Catalyzed Halogenation in Nucleotide Biosynthesis

Project Summary/Abstract
Iron and 2-oxoglutarate-dependent (Fe/2OG) enzymes, representing a superfamily of non-heme mononuclear
iron-containing (NHM-Fe) enzymes, have garnered strong research interests from fundamental enzyme
mechanism studies to bioengineering/biocatalysis explorations in recent years due to their exceedingly diverse
catalytic reactivities and simple enzyme architectures. Radical halogenation reactions via C-H bond activation
catalyzed by Fe/2OG halogenases are particularly attractive for chemical synthesis and biocatalysis applications,
since these enzymes can install carbon-halide bonds in a regio- and stereo-specific manner, a feat that has yet
to be achieved by organic synthetic methodology. As revealed by the mechanistic studies of carrier protein-
dependent Fe/2OG halogenases, the key step in the radical halogenation mechanism is the selective halide
radical transfer from the hydroxo-Fe(III)-halide intermediate to the substrate radical generated by the key reactive
species, the ferryl (Fe(IV)=O) intermediate. However, a consensus mechanism to explain the selective halide
transfer in Fe/2OG halogenases has not been reached, particularly the controlling factors to avoid hydroxyl
radical transfer to lead to hydroxylation reaction are not fully revealed. Additionally, the reasons why Fe/2OG
enzymes cannot perform fluorination reaction are completely unknown. In this project, we will bridge these
knowledge gaps by studying two newly discovered carrier protein-independent Fe/2OG halogenases that
catalyze chlorination reactions to generate halogenated nucleotide natural products and halogenated free-
standing amino acids. By using an integrative approach consisting of mechanistic probe design and synthesis,
enzyme product structural determination via LC-MS and NMR analysis, transient enzyme kinetics, advanced
spectroscopic characterization and molecular dynamics simulations, we will elucidate the influence of protein-
substrate interactions and dynamics in controlling efficient halogenation, explore the effect of different iron-bound
anions (e.g. Cl- vs. F-) to the electronic structure and the reactivity of the ferryl intermediate, test new chemical
strategies to enable fluorination in Fe/2OG enzymes, and expand the substrate scope of these enzymes for
potential synthetic applications. Given the importance of halogen-containing organic molecules in the modern
pharmaceutical and agrochemical applications, mechanistic elucidation of these newly discovered halogenases
will lay scientific foundation for future biocatalytic applications of these unique enzymes.

Public health relevance
Project Narrative Halide-containing nucleosides and nucleotides represent an important family of synthetic drugs for anticancer and antiviral treatments, thus it is essential to develop novel and effective synthetic strategies to expand halogenated nucleoside/nucleotide compound library for drug discovery. Radical halogenation via carbon- hydrogen bond activation catalyzed by iron and 2-oxoglutarate (Fe/2OG) dependent enzymes represents an attractive strategy to install carbon-halide bonds in a regio- and stereo-specific fashion. In this projects, two newly discovered Fe/2OG enzymes that catalyze radical halogenation to generate halide-containing nucleotide natural products and amino acids will be mechanistically investigated, the obtained mechanistic insights will be further deployed to develop these enzymes into biosynthetic platform to access new halide-containing nucleotide/nucelosides.